Differentiating Primary and Secondary Subtypes of Callous Unemotional Traits During Early Childhood

PROJECT SUMMARY
Childhood disruptive behavior disorders (DBDs) are one of the most common forms of psychopathology in
children, with a worldwide pooled prevalence of nearly 6%. Much research has linked the presence of callous-
unemotional (CU) traits (i.e., low empathy, guilt, and prosociality) to increased risk for severe DBDs across
development. Moreover, children with DBDs and CU traits show poorer treatment outcomes when compared to
children with DBDs alone. Heterogeneity within the clinical phenotype of CU traits is thought to compound this
treatment gap. In particular, children with CU traits can be further differentiated into primary (i.e., low fear, low
anxiety) and secondary (i.e., anxiety and trauma) subtypes. Theoretical models suggest that primary and
secondary CU traits develop through distinct etiological pathways. However, the physiological mechanisms
which underlie the development of these subtypes are not well understood and studies have yet to use advanced
machine learning techniques to derive biologically informed subtypes. Here, I propose that the development of
CU traits occurs via two distinct etiological pathways underpinned by unique profiles of physiological reactivity
and exposure to adversity. As part of an ongoing, longitudinal study, preschool aged children (n=500) complete
a variety of behavioral tasks while parasympathetic nervous system (PNS) function, as indexed by respiratory
sinus arrythmia (RSA), is measured. Parent-reported questionnaires assessing CU traits, DBDs, anxiety, and
exposure to adversity are also collected. I hypothesize that RSA will differentially predict CU trait at baseline and
2-year follow-up, such that higher RSA will be related to CU traits for children exposed to more adversity, and
lower RSA will be related to CU traits for children regardless of exposure to adversity (Aim 1). Additionally, I
hypothesize that a novel semi-supervised machine learning algorithm will identify “biotypes” of CU traits based
on patterns of PNS function. Specifically, I expect to find a primary profile characterized by low levels of RSA
across tasks, associated with lower anxiety and fearlessness, and a secondary profile characterized by high
levels of RSA, associated with anxiety and emotion dysregulation (Aim 2). The overarching goal of this proposal
is to gain a better understanding of how subtypes of CU traits develop based on distinct patterns of physiological
reactivity in the context of differential exposure to adversity. These findings can inform etiological models of CU
traits, while simultaneously informing early identification and precision treatment of childhood DBDs. With
guidance from a strong mentorship team with relevant expertise (Drs. Waller, Wagner, Kimonis, Davatzikos, and
Zisser), my proposal and the accompanying training plan provide an ideal foundation for my planned career as
an independently funded, leading clinical scientist studying biomarkers of externalizing psychopathology.

Public health relevance
PROJECT NARRATIVE Children with callous-unemotional (CU) traits can be differentiated into primary and secondary subtypes, which are hypothesized to develop through distinct etiological pathways. This proposal examines how distinct patterns of physiological reactivity, measured by parasympathetic nervous system function, and exposure to adversity underpin these two subtypes of CU traits in early childhood. Findings can contribute to better knowledge of how environmental and biological factors give rise to primary versus secondary CU traits, while also informing precision diagnostics and targeted treatments within the field of childhood disruptive behavior disorders.